Advancing Neurosurgical Neuronavigation Using Resting State MRI and Machine Learning

Abstract. Long-term survival of patients with glioblastomas (GBM) are associated with two competing priorities:
1) gross total resection and 2) preservation of the patient’s function. Stereotactic navigation, in which
reconstructed magnetic resonance images (MRI) of the brain are used for real-time intraoperative anatomic
guidance, has become an essential tool for tumor resection. Further, there are emerging insights that glioma-
specific perturbations of the functional organization of the brain impact the patient’s survival. However, the
current barrier is that there is no FDA approved navigation system that enables the surgeon to visualize the
functional architecture of the brain and the impact a tumor has on the brain’s network organization to inform
prognosis. Resting state functional MRI (rs-fMRI) has emerged as a powerful tool for mapping clinically relevant
brain networks and defining critical glioma-neuronal interactions. rs-fMRI is highly efficient, task independent,
and multiple resting state networks (RSNs) can be mapped simultaneously. With this in mind, the long-term goal
of our research is to improve treatment, survival, and quality of life for patients with brain tumors by improving
the identification of eloquent cortex and providing actionable metrics for survival prognosis to best tailor a
patient’s care. In our first Academic Industry Partnership between Washington University and Medtronic we were
extremely productive in creating an integrated brain-mapping navigation technology using rs-fMRI. Specifically,
we created a robust image acquisition/analysis pipeline that includes pre-processing of raw data, quality control
analytics, and clinical validation demonstrating superior performance over task-based fMRI. We have also been
leaders in deriving prognostic radiomic biomarkers from rs-fMRI. In this continuation, we will build on these
successes. The overall objective is to create advanced rs-fMRI machine learning (ML) tools to more efficiently
and accurately define functional cortex and provide preoperative prognostic metrics of survival as a
comprehensive surgical/care navigation system. We have the expertise, infrastructure, and data, to advance rs-
fMRI to be a powerful tool for neurosurgical decision support. The proposal entails three specific aims: 1)
Advance an ML algorithm to enable more accurate and data efficient rs-fMRI brain-mapping software, 2) Create
an rs-fMRI ML algorithm to preoperatively predict survival in glioblastoma (GBM) patients, and 3) Validate impact
of mapping and prognostic algorithms on clinical decision making in prospective feasibility clinical trial. The
expected outcome of this work will be an integrated imaging/surgical navigation technology using rs-fMRI for
clinical decision support with defined performance, clinical validation, and a regulatory path for FDA clearance.
Thus, this proposal is innovative because 1) the software will map networks with substantially shorter image
acquisition times, thus enabling more widespread adoption and 2) provide critical pre-operative survival insights
to inform surgical decisions. This work is significant because it will disseminate technology that fundamentally
enhances more tailored approaches to improving patient outcomes and quality of life.

Public health relevance
Project Narrative The proposed research is an academic industry partnership that will make available to neurosurgeons and neuro- oncologists a neuronavigation capability that will optimize treatment of patients with brain tumors by more efficiently and accurately localizing critical brain regions and providing prognostic information on the patient’s survival. This development is relevant to public health because it will assist clinicians to personalize patient treatment planning, including surgical strategy and subsequent oncologic care. Towards this end, we propose to create an imaging technology package that will integrate advanced machine learning techniques using resting state functional magnetic resonance imaging with an existing widely used neuro-anatomic navigation system currently used by neurosurgeons. The integrated system, which will include anatomic, functional, and prognostic information, will provide a more comprehensive patient assessment to maximize safe and effective treatment.